Enhancing Biomedical Infrastructure and researcher Capacity through the Acquisition of Class II, Type A2 Biosafety Cabinets

Principal Investigator: Tinoco, Arthur D.
Project Abstract
Funds are being requested for the purchase of three REDISHIP Purifier® Logic®+ Class II A2 Biosafety cabinets
to replace three obsolete cabinets and renovate a Cell Culture Facility within a developing Omics Center at the
Facundo Bueso Research Building of the University of Puerto Rico Rio Piedras Campus. This renovation is part
of a bigger vision to modernize STEM infrastructure and encourage interdepartmental communication at the
university to counter the debilitating events of recent natural disasters and major economic budget cuts and expand
researcher capacity and bandwidth by providing additional resources and tools that will foster research student
development and fortify and enhance the training of biomedically oriented laboratories. The cabinets will be used
for studies involving mammalian cells/tissue with two of the cabinets located in a room exclusively dedicated to
research and the third in a separate room primarily for training and, as needed, to also accommodate any
temporary/emergency researcher needs. A diverse team of End User researchers spanning different departments
and campuses has been established consisting of Drs. Tinoco, Díaz Ayala, Díaz Vázquez, Colón, Weiner, Cunci,
Montes, Rodríguez Berríos, Griebenow, Peterson, and Fernández Vega. This team consists of early career and
senior level researchers combining a wide spectrum of expertise judiciously selected to facilitate a variety of
experiments through interdisciplinary collaborations. Research projects by this team will address important
health-related questions by engaging in drug development and delivery, mechanistic studies in cancer biology,
and the design and testing of sensors for detection of human ailments. With dedicated space for training, several
training modules for performing different types of cell-based experiments will be created to enrich End User
laboratories with more in-depth technical orientation. Access to the Cell Culture Facility will be promoted to other
investigators in the different departments of the College of Natural Sciences and, where possible, nearby
universities. Additional users will be recruited through introductory trainings that will be offered to faculty and
students of the NIH RISE program, the Chemistry and Biology graduate programs, and the summer high school
and undergraduate internships (for example ACS Project SEED and REU: PR-CLIMB). Other trainings may be
possible through STEM education efforts such as the creation of a new laboratory experience for the Chemistry
Department Biochemistry Lab course.

Public health relevance
Principal Investigator: Tinoco, Arthur D. Project Narrative This project seeks to renovate a Cell Culture Facility within a developing Omics Center by acquiring three state of the art Class II A2 biosafety cabinets that can expand researcher capacity to perform a variety of experiments involving mammalian cells/tissues for human health application. The team of End Users that have been assembled to use the cabinets consist of early career and senior level scientists of different departments that will foster interdisciplinary projects and collaborations focused on drug development and delivery, mechanistic studies in cancer biology, and the design and testing of sensors for detection of human ailments. One of the cabinets will be placed in a dedicated space for providing introductory and specialized trainings to a wide body of student and faculty researchers.